Cardiorespiratory Pharmacodynamics of Fentanyl-Xylazine

PROJECT SUMMARY
Xylazine has become an increasingly common adulterant that is often unknown to the user. The combination of
xylazine with fentanyl is particularly prominent with xylazine now recognized as an escalating factor in fentanyl
overdose deaths. How xylazine potentiates fentanyl toxicity including the basic dose/response, however, remains
unclear. Both fentanyl and xylazine produce respiratory depression and it is generally accepted that co-
administration increases potency for both, thereby enhancing the potential for profound hypoventilation that if
left untreated can lead to hypoxic organ damage and death.
Less well appreciated is that unlike fentanyl, intravenous xylazine has significant direct adverse cardiovascular
effects that can lead to substantial reductions in blood pressure and cardiac output (whole body blood flow).
Implications of this in the context of co-administration are two-fold. First, while the brain and other vital organs
exhibit intrinsic autoregulatory responses to maintain blood perfusion and oxygen delivery over a range of blood
pressure and blood flow, this autoregulation has limits when the blood pressure is very low and/or metabolic
disturbances such as acidosis are superimposed. Recently published data indicate that, at least for the brain,
xylazine also blocks some aspects of cerebral autoregulation that are not significantly altered by fentanyl alone.
Second, since oxygen delivery to tissues is the product of both the oxygen content of arterial blood and blood
flow, xylazine may enhance fentanyl toxicity by not only potentiating respiratory depression to produce
hypoxemia but also by reducing organ perfusion. Additionally, in that fentanyl is metabolized in the liver and
clearance is largely dependent upon hepatic blood flow, it is possible that xylazine-induced reductions in cardiac
output may also enhance fentanyl toxicity by impairing its clearance.
Currently, there are no controlled robust data specifically defining how the dose/respiratory response for fentanyl
is altered by xylazine (or vice versa), how xylazine may enhance fentanyl toxicity by further impairing oxygen
delivery, or whether xylazine alters fentanyl clearance. The proposed studies will address these fundamental
knowledge gaps using anesthetized swine extensively monitored to provide assessment of a wide range of
respiratory, cardiovascular, and metabolic endpoints as well as biochemical makers of end-organ damage.
Importantly, since the doses associated with clinical toxicity manifest as respiratory depression are unknow, we
will first define within the experimental model of this exploratory study the dose/respiratory depression response
relationship for fentanyl and xylazine individually and use these data to guide subsequent co-administration
studies.

Public health relevance
PROJECT NARRATIVE The proposed exploratory studies are specifically relevant to a recent public safety alert issued by the DEA and DOJ regarding the enhanced lethality of fentanyl when co-administered with xylazine. The proposed research will systematically evaluate the dose/response for toxic side effects of each drug individually and in combination to define interactions and potentially identify actionable clinically relevant endpoints to improve outcome.